Mechanisms determining tumor-selective potency of RAS pathway inhibitors

Summary
The RAS/RAF/MEK/ERK (RAS/MAPK) signaling pathway is an established driver of many cancers, commonly
hyperactivated by genetic alterations in RAS or BRAF. RAF and MEK inhibitors (RAFi and MEKi) have been
clinically successful in BRAF-mutant (BRAF-MUT) tumors, but their clinical efficacy in RAS-mutant (RAS-MUT)
tumors has been so far modest, limited by toxicities. Based on the experience with BRAF-MUT tumors, we posit
that clinical efficacy of RAS pathway-targeting inhibitors requires selective MAPK inhibition in RAS-MUT tumors
over RAS-WT normal cells. To achieve such RAS-MUT tumor-selective potency of RAS pathway inhibitors, we
need better understanding of how RAS activation affects target drug binding and MAPK inhibition in cells. The
goal of this proposal is to accomplish a better understanding of how the cellular context affects tumor-selective
therapeutic potency of RAFi and MEKi, with the goal of designing more effective therapeutic strategies for RAS-
MUT cancers. Our preliminary findings suggest that RAS activation differentially affects RAFi binding to RAF
paralogs, as well as their protein stability. We have further evidence that although RAFi suppress MAPK
preferentially in RAS-MUT over RAS-WT normal cells, combinations of RAFi and MEKi result in similar MAPK
inhibition in the two contexts, they are thus predicted to promote dose-limiting toxicities. Our hypothesis is that
RAS activation affects protein expression levels and conformations of RAF paralogs and MEK resulting in
differential binding to RAFi and MEKi, determining tumor-selective MAPK and cell growth inhibition by these
drugs. This hypothesis will be tested in three Aims: Aim 1 will characterize differential RAFi binding to RAF
paralogs in RAS-MUT and normal cells using in-cell binding assays and structural and biophysical approaches.
Aim 2 will define effects of RAS activation on RAF paralog protein stability and expression. Aim 3 will characterize
biochemically, biophysically and in vivo combinations of diverse RAFi and MEKi to determine whether the lack
of tumor-selective suppression of MAPK signaling in RAS-MUT tumor over RAS-WT normal cells increases
toxicity and limits the efficacy of combined RAFi+MEKi.
The proposed research will develop experimental tools and concepts to delineate mechanisms determining
differential potency of RAFi and MEKi in RAS-MUT over normal cellular contexts. Defining such mechanisms
should enable the rational design of more effective RAS pathway-targeting drugs and drug combinations for the
treatment of RAS-MUT cancers.

Public health relevance
Project Narrative Targeting RAS-mutant tumors using RAF and MEK inhibitors has shown preclinical promise, but only modest results in the clinic. Our preliminary data indicate that the extent of tumor-selective inhibition of MAPK signaling by these drugs is determined by paralog and conformation selectivity of different biochemical classes of RAF and MEK inhibitors. This proposal is aimed at elucidating mechanisms determining tumor-selective potency of RAS pathway inhibitors to enable the design of more effective therapies for RAS-mutant cancers.